Implications of Spatiotemporal Deep Learning Neural Networks in Echocardiographic Diagnosis and Prognostication of Takotsubo Syndrome

Project Summary/Abstract
Differentiating Takotsubo syndrome (TTS) from acute myocardial infarction (AMI) is often challenging in real
time. Meanwhile, the poor phenotypic grouping of TTS patients prevents investigation of effective therapeutic
strategies for long-term risk reduction. Built on our current study that already yielded an accurate and broadly
applicable spatiotemporal deep convolution neural network (DCNN) for echocardiographic diagnosis of TTS,
in this proposal, we plan to augment and optimize a DeSeg-TTSD algorithm using large-scale multi-institution
and multi-vendor echocardiographic datasets, as well as clinical metadata to increase the robustness,
generalizability, and interpretability of deep learning modeling in real-time imaging analysis. We also plan to
develop and validate a DeSeg-TTSP model for TTS prognostication and phenomapping by extracting latent
spatiotemporal features correlating with TTS pathophysiology and outcome, so as to develop personalized
treatment.
We hypothesize that, when trained on an echocardiographic video task, a spatiotemporal DCNN can unlock
sub-visual predictive information with advanced learning and computational analysis, to discover distinctive
myocardial motion patterns and assimilate latent spatiotemporal imaging features to improve the accuracy of
diagnosis and prognostication for TTS patients.
The proposed research project brings together multiple innovations: It is based on a solid scientific premise,
builds on already achieved results and extends state of art of spatiotemporal deep learning modeling in real
time imaging, to provide decision support for clinical diagnosis and prognostication using imaging information
routinely available in daily practice. Other than our local research team assembling imaging engineering
experts, cardiologists and statisticians, an inter-institutional team including 57 board-certified expert human
readers will perform human classification, data visualization and evaluate the feasibility of the application and
integration into a clinical setting of the established and validated DL model.
We will fulfill the following specific aims
1: Develop and validate fully automated spatiotemporal DL diagnosis models from echocardiographic videos
that enable discrimination of TTS from AMI in real time.
2: Integrate spatiotemporal DL prognostication into clinical prediction models to endorse long-term TTS
prognostication.
3: Perform data visualization on spatiotemporal DL framework and investigate TTS pathophysiology to develop
personalized treatment
Establishing this spatial-temporal hybridized deep learning framework will become a foundation for the
development of additional precision medicine decision support tools for patients with acute cardiovascular
disorders to address urgently-needed diagnostic decisions, resolve time-sensitive therapeutic dilemmas and
obtain advanced imaging markers to develop specific primary and secondary prevention strategies.

Public health relevance
Project Narrative This work can positively impact public heath by providing real time diagnosis and prognosis determination and decision support for clinical patients with Takotsubo Syndrome with more objective and innovative spatiotemporal deep learning prediction models based on routinely available bedside imaging approaches. This proposed research is relevant to the NIH mission as it enables frontline clinicians to resolve time-sensitive diagnostic and therapeutic dilemmas and obtain advanced bioimaging markers to develop personalized treatment in patients with acute cardiovascular disorders.